Probing the unique attributes of the naïve reservoir

Resting CD4+ T cells form a reservoir capable of refueling HIV viremia when treatment is stopped. This is a
major barrier to an HIV cure. Resting CD4+ T cells can be divided into naïve and memory subtypes. It was
previously thought that naïve T cells formed a negligible portion of the reservoir, as the total amount of HIV DNA
in the naïve pool is small. We have shown, however, that there is relatively more intact than defective HIV DNA
in the naïve T cells compared to memory T cell subsets. In fact, in chronic progressors with X4 tropic virus, naïve
are often the major contributor to the HIV reservoir. Moreover, the integration sites and proviral sequences of
the HIV DNA in naïve cells are more diverse than in the memory subsets, indicating that the proviruses originated
from many different infection events. Naïve T cells have a much longer lifespan than memory T cells, higher
proliferative potential, and apparent resistance to clearance, which suggest that this naïve T cell reservoir is
capable of repopulating the HIV reservoir. The formation of the naïve reservoir by CCR5-tropic viruses is still
somewhat mysterious, as naïve cells in the blood do not usually express the CCR5 co-receptor, but preliminary
data shows that naïve cells in lymphoid tissues show different expression patterns, including occasional
expression of CCR5. Overall objective: We will quantify the contribution of naïve cells to the reservoir in donors
that represent a spectrum of reservoir size (Aim 1). We exploit our exciting finding that elite controllers have
nearly absent naïve T cell infection, while naïve infection serves as a prognostic indicator in chronic progressors.
We will dissect the heterogeneous nature of naïve T cells, especially in lymphoid tissue, as has previously been
done for memory T cells using RNA sequencing (Aim 2). We will elucidate important naïve biology and determine
how naïve T cells become infected. Design and Methods: In Aim 1, led by Dr. O'Doherty, we quantify the
contribution of naïve T cells to the entire HIV reservoir in both size and diversity using sophisticated sequencing
techniques, unique bioinformatic approaches (Dr. Polson), and math modeling (Dr. Zurakowski). We will also
study the ability of naïve T cells to replenish the reservoir and evade the CTL clearance. In Aim 2, led by Dr.
Levy, we couple RNAseq with antibody barcoding to identify memory and naïve T cells with elevated levels of
CCR5. We will probe the mechanism of naïve cell infection by infecting subset and bulk T cells from lymphoid
tissue and blood. We will determine viral tropism phenotypically, and monitor for reversion to naïve phenotype
ex vivo. These studies will also provide insights into the signaling pathways that distinguish naïve T cell subsets,
and that determine their susceptibility to HIV. The premise of our proposal is largely based on our prior work that
has shone a light on the role of naïve T cells and simultaneously provided insights into why these cells have
previously been ignored. This proposal may lead to a greater focus on naïve T cell infection, as these cells are
well-suited to hide proviruses. Focused attention on this entirely different cell type will be necessary to eradicate
HIV.

Public health relevance
HIV previously research than investigate participants, infection can hide in resting T cells, which come in two types: memory and naïve. It was thought that the HIV levels in naïve cells were so small as to be unimportant, but our has shown that the HIV-infected naïve T cell pool is much larger, and more significant, previously thought, and represents a critical barrier to an HIV cure. This project will the size and characteristics of the pool of HIV-infected naïve T cells in HIV-infected and investigate the properties of naïve T cells that allow them to become infected.